Hepatocytes and skeletal myocytes shape immunity to mRNA-LNP encoded protein

PROJECT SUMMARY
Applications for messenger RNA (mRNA) in a wide range of clinical indications—such as pathogen
vaccination, cancer immunotherapy, protein replacement, and gene editing—are rapidly advancing. Since
Moderna and Pfizer’s mRNA vaccines against SARS-CoV-2 highlighted the efficacy and potency of mRNA
technology, there has been ongoing effort to optimize the formulation of the mRNA and the delivery vehicle,
which is often a lipid nanoparticle (LNP), for novel applications. One of the major challenges faced by mRNA
therapeutics, even those that have targeting moieties, is mRNA uptake and expression by off-target cells. Current
mRNA vaccines depend on antigen presentation by antigen-presenting cells (APCs) to induce robust immunity,
yet hepatocytes and skeletal myocytes are also transfected, leading to unintended immune modulation. To better
understand how these two cell types influence adaptive immunity to the mRNA-encoded protein, I will regulate
the cellular expression patterns of delivered mRNA by incorporating target sites complementary to cell-type
specific, endogenous miRNA. My preliminary data indicate that hepatocytes dampen the magnitude of CD8+ T
cell responses to the mRNA-encoded antigen, whereas skeletal myocytes enhance CD8+ T cell responses.
Understanding the mechanisms underlying the immunomodulatory effects of these two cell types is crucial for
optimizing mRNA-based therapeutics. My central hypothesis is that hepatocytes drive an
immunoregulatory response to mRNA-encoded protein through abortive CD8+ T cell stimulation and
regulatory T cell (Treg) induction, while skeletal myocytes can directly present antigen to and activate
CD8+ T cells. I will engineer clinically-relevant mRNA formulations with regulated mRNA expression in
these two cell types to enhance antigen-specific adaptive immunity while reducing deleterious off-target
effects. In Aim 1, I will delve into the mechanisms by which hepatocytes and skeletal myocytes modulate
antigen-specific T cell immunity against the mRNA-encoded protein. I will specifically evaluate the effect of Treg
depletion and hepatocyte-restricted antigen presentation on CD8+ T cell responses. To assess the role skeletal
myocytes may play, I will evaluate the duration of antigen presentation and whether skeletal myocytes are
sufficient to induce T cell recall. I will also investigate whether exogenous antigen uptake by APCs can induce
antigen-specific T cell immunity. In Aim 2, I will leverage the impact of mRNA expression by hepatocytes and
skeletal myocytes to enhance antigen-specific adaptive immune responses to tumor-associated antigen (TAA)
and SARS-CoV-2 spike mRNA vaccines, while reducing off-target cytotoxicity from CD8+ T cells, especially in
the liver. I will design mRNA vaccines to boost anti-TAA CAR-T cells, induce exogenous anti-tumor CD8+ T cell
activity, and enhance anti-spike antibody and T cell responses. Ultimately, this project aims to provide insight
into design strategies for mRNA vaccines to tailor immunogenicity while minimizing adverse effects.

Public health relevance
PROJECT NARRATIVE Non-immune cells that take up mRNA delivered by lipid nanoparticle include hepatocytes and skeletal myocytes. Although there is an urgent need to better understand the mechanisms driving immunity to mRNA- encoded proteins, there is limited data describing how these specific cell types modulate the antigen-specific adaptive immune response. The objective of this proposal is to comprehensively interrogate the mechanisms by which these cell types modulate immunity and to leverage microRNA-mediated regulation of mRNA expression to enhance immunity induced by an established tumor-associated antigen and pathogen vaccine strategies.